Clinical Trial Readiness for Monitoring Muscle Inflammation in Duchenne Muscular Dystrophy

Abstract
Duchenne muscular dystrophy (DMD) is caused by mutations of the X-linked DMD gene, with the majority of
mutations now occurring as de novo events due to the high mutation rate. The DMD gene is also one of the
largest in the human genome, with 79 exons covering 2.3Mb of Xp21. Carrier screening is problematic due to
high mutation rate and large gene size, and the incidence of DMD has not declined significantly over the last
decade, remaining at about 1/5,000 live born males. The disease is progressive, with onset of skeletal muscle
pathology (inflammation, degeneration/regeneration) present from birth, but clinical symptoms of proximal
muscle weakness typically not recognized until early school age (~4 to 6 years). DMD boys typically lose
ambulation in the second decade and succumb to respiratory or cardiac failure in 3rd decade unless ventilated.
Clinical trials in DMD have expanded dramatically over the last decade, and 5 drugs have been approved.
However, 4 of these approvals were based on accelerated approval with dystrophin expression in skeletal
muscle as the primary outcome (surrogate biomarker) and clinical efficacy has not yet been demonstrated.
Indeed, the approvals of exon skipping drugs have been highly controversial within FDA and clinical research
community. The only drug approved on clinical outcomes is deflazacort, with approval based on an academic
trial done decades earlier, and this approval was also controversial. Thus, there are no drugs approved based
on clinical outcomes in contemporary trials, with many more recent clinical trials using clinical outcomes
measures failing to show efficacy based on motor outcomes. A challenge with DMD clinical trials is the
progressive nature of the disease with appropriate motor outcomes changing as function of patient age, and
the lack of blood biomarkers able to monitor drug effect on muscle inflammation or fibrosis, and/or predict later
changes in motor outcomes. In this application for clinical trial readiness in DMD, we propose the study of two
serum biomarkers of inflammation, MDC and CD23, that we have previously shown to be responsive to
corticosteroid anti-inflammatory treatment in 4 disease states (pediatric DMD, pediatric inflammatory bowel
disease, juvenile dermatomyositis, and adult vasculitis). These biomarkers were also shown to be dose-
responsive to vamorolone, a novel dissociative steroidal drug under development in DMD, within 2-weeks of
treatment, and aided in dose-selection for the recently completed confirmatory, pivotal trial (VBP15-004) in 121
DMD boys. The proposed aims are to determine the extent to which drug-related reductions in MDC and/or
CD23 at 3 months treatment anticipate clinical improvement of motor outcomes at 6 months and 12 months
treatment. The double-blind VBP15-004 trial randomized DMD boys into 4 arms (placebo, vamorolone 2.0
mg/kg/day, vamorolone 6.0 mg/kg/day, prednisone 0.75 mg/kg/day), and included a cross-over of placebo and
prednisone to vamorolone at study midpoint. The VBP15-004 demonstrated efficacy of both 2.0 and 6.0
mg/kg/day vamorolone groups vs. placebo (met primary and 4 sequential secondary outcomes) and showed
improved safety vs. prednisone (no stunting of growth, no deleterious changes in bone biomarkers). The
anticipated result is that MDC and/or CD23 predict later motor outcomes and can then be routinely integrated
into DMD clinical trial designs to monitor systemic and/or muscle inflammatory state.

Public health relevance
Narrative Duchenne muscular dystrophy is a progressive neuromuscular disorder caused by loss of dystrophin protein in skeletal muscle and heart. There is an unmet need for serum biomarkers that can be employed to de-risk drug development programs, and further provide objective biomarker outcomes on muscle disease and pathologies in DMD. The proposed research investigates whether drug-related reductions in two inflammatory serum biomarkers, MDC and CD23, predict later clinical motor outcomes in DMD.